U2C/TL1 NC KUH TRIO Program

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The NC KUH TRIO Networking Core is designed to build a pipeline of talented trainees who will contribute to KUH related fields across NC institutions of higher learning. We aim to provide support to this pipeline as part of a dynamic and cohesive cohort along their training pathway towards successful and rewarding careers in research. By connecting programmatic and established partners across 3 leading North Carolina (NC) biomedical research universities: University of North Carolina-Chapel Hill, Wake Forest University, and Duke University, and from three smaller NC Universities with strong science, technology, engineering and mathematics (STEM) degree programs, NC Agricultural & Technical State University, Winston-Salem State University and NC Central University, the TRIO Networking Core is poised to reach a broad spectrum of trainees interested in science and research. Networking Core activities will connect early-stage STEM trainees to peers, near-peer trainees, and senior mentors, which will be enhanced through the integration of social media and virtual learning platforms in addition to traditional in-person group learning opportunities, conference meetings, and community outreach events. Together, these activities will support the TRIO Networking Core’s three objectives to: 1) organize a pipeline with a leadership structure built to recruit and support development of the workforce needed to serve the communities impacted by KUH-related diseases, leveraging existing, and creating new KUH-specific programs especially for undergraduate college learners; 2) support the talent of our trainees as emerging interdisciplinary leaders across all levels of KUH-related research by equipping them with the skills required to conduct scientific, collaborative research ; and 3) enhance retention of trainees across the KUH pipeline through community building trainee activities. Close collaboration with the TRIO Professional Development, Training (TL1), and Administrative Cores will provide resources and infuse the Networking Core with the mentors and tools to build the bridges for undergraduate trainees and maintain an open gateway of support for the next generation of researchers. These efforts support the overall goal of nurturing fully prepared researchers who will advance KUH research and advance our goal of developing a strong workforce to advance research and improve outcomes for the broad spectrum of KUH diseases and conditions.

Public health relevance
It is imperative to train researchers in clinical, scientific and technological areas to advance the fields of Kidney, Urology and Hematology (KUH) towards bringing better understanding and management to KUH conditions and diseases. This program in North Carolina combines expertise and novel concepts in Training, Research, Innovation, and Outreach to form the NC KUH TRIO Program, bringing together six institutions across the state; 3 academic medical centers and 3 smaller N.C. universities that have strong science, technology, and engineering programs. TRIO will support pre- and post-doctoral trainees, providing them with innovative research tools and a professional development foundation to launch KUH research careers.